Data Science Core

Project Summary: Data Science Core
The main purposes of the Data Science Resource Core are to collect, manage and distribute
experimental data, to visualize the analyzed results such as structure and activity, and to
provide an interface for users to use our designed methods on both imaging data and omics
data. This digital infrastructure will be implemented in the form of a multi-tier services-oriented
architecture. The products of the other Research Projects will be collected via protocols that are
amenable to a digital representation. These will then be unified via spatial registration in a
common coordinate system. Ensuring that the data have appropriate landmarks and that
measurements of the spatial extent of key images is a core operation for this endeavor. With
data whose content is appropriate for unification, it will subsequently be determined which digital
format representation is most suitable for each data type, with the goal of making them easy to
present in an online interface for the consumption of the broader scientific community. Data files
with the appropriate format will be made available on the public internet. From here, a user-
friendly web-based interface will be designed and implemented on top of a platform for
astrocytic data visualization, that itself reuses best-in-class open-source visualization software
for the web. The interface will ensure that users can easily navigate between individual data
sets and also can visualize relationships between data sets across the domains from the other
Research Projects. The interface will enable the user to explore imaging data of astrocytes
collected at different positions of the brain, as well as the omics expression pattern at the
corresponding area. The interface will also provide the visualization of the astrocyte network. To
encourage broad sharing of the data resources produced, high quality metadata will be created
to include with the data that conveys its provenance. Data products will be enabled to have their
own digital object identifiers (DOIs), incorporate compatibility with ORCID ids, and embed
RRIDs into the system as necessary. Core data products will further be shared through key
federally supported data sharing resources and by applying best practices to data format and
dissemination techniques used. The data analysis method will also be made available for users
as web-based computational services for users to analyze their own data.